Dissecting and targeting oncogenic functions of PAK4 in high-risk rhabdomyosarcoma

PROJECT SUMMARY/ABSTRACT
Rhabdomyosarcoma (RMS) is the most common soft tissue sarcoma in children and adolescents. Overall,
survival rates for RMS are approximately 65-70%. However, despite intensification of chemotherapeutic
regimens, long-term outcomes for patients with metastatic or relapsed rhabdomyosarcoma remain extremely
poor, with overall survival rates between 20-30%. Thus, alternative targeted therapies are essential for improving
patient outcomes. Our proposal will address a significant gap in the knowledge and treatment of high-risk
rhabdomyosarcoma. RMS tumors have frequent mutations in the RAS/NF1 pathway and perturbations in the
receptor tyrosine kinases (RTK)/RAS/phosphoinositide 3-kinase (PI3K) signaling axis, which are associated with
high-risk conditions. The p21-activated kinases (PAK) family of serine/threonine kinases intersects the oncogenic
signaling by RTK and RAS-activated pathways. Downstream PAK signaling regulates metastatic phenotypes
and resistance to therapeutics, thus making them attractive targets for advanced cancers. Based upon extensive
informatic, functional genomic, biochemical interactome and pharmacological data we have evidence that PAK4
regulates intrinsic and extrinsic mechanisms, including alternative splicing(AS) and immune modulatory signals,
that contributes to RMS progression. In addition, using high-throughput combination drug screens we identified
mechanistically rational and clinically applicable synergistic therapeutic regimens with PAK4 inhibition. The
overarching goals of our proposal are to gain critical molecular insights into novel PAK4-mediated mechanisms
and further investigate the therapeutic potential of targeting PAK4 in RMS. We will examine PAK4’s role as a
novel regulator of AS and PAK4-mediated downstream transcriptomic and proteomic signatures that contribute
to RMS progression through the use of our extensive inventory of highly relevant human and syngeneic murine
pre-clinical models. We hypothesize PAK4 regulates critical intrinsic and extrinsic molecular signatures vital for
RMS progression, and PAK4 inhibitors in combination with rational targeted agents can provide effective novel
therapeutic regimens for these high-risk patients. We propose three independent, yet innovative and novel
complementary aims to address this hypothesis. Aim1. Evaluation of PAK4 as a novel splicing regulating protein
kinase and its direct effects on downstream signaling in RMS. Aim 2. Role of PAK4 in modulating the tumor
microenvironment and identification of therapeutic applications using relevant murine pre-clinical models of RMS
developed in our lab. Aim3. Investigate the therapeutic potential of inhibiting PAK4 in combination with
mechanistically rational targeted agents using innovative ex vivo 3D lung metastasis models and in vivo
orthotopic and metastatic RMS models. Completion of these studies will provide novel molecular insights into
RMS biology and impact RMS therapy by providing new therapeutic strategies that can be quickly moved towards
clinical trials for the treatment of relapsed or metastatic RMS.

Public health relevance
PROJECT NARRATIVE Rhabdomyosarcoma (RMS) is a highly malignant skeletal muscle tumor, with frequent activation of the Ras signaling pathway, and poor outcomes for patients with relapsed or metastatic disease. We have identified that PAK4 as a key signaling node in RMS and will validate it as a new therapeutic target, in combination with chemotherapy or other targeted agents, for high-risk RMS. The proposed research is relevant to public health and the NIH's mission because understanding and validating new therapeutic targets for pediatric sarcomas will improve the treatment of such tumors while minimizing toxic effects of current therapy.